Signaling Cascades in Regulation of Pancreatic Beta cell mass.

[unreadable] DESCRIPTION (provided by applicant): Decrease in beta cell mass by apoptosis represents the key turning point in the manifestation of both type 1 and type 2 diabetes. The molecular basis of beta cell death is not well understood and remains an intense area of research. While several independent triggers can initiate the death pathway, activation of the stress kinase JNK is required in most cases for apoptosis of beta cells. At the same time, the inhibition of anti-apoptotic Akt kinase and other prosurvival pathways is also required for the acceleration of apoptosis. In beta cells the stress kinase pathway is executed in a three-tiered module consisting of MAPKKK, MAPKK, and JNK. The existence of multiple MAPKKKs belonging to distinct families has obscured our understanding of how a variety of stimuli including cytokines, oxidative stress, DNA and UV damage lead to highly specific responses by the engagement of specific MKKKs. Furthermore, the high level of complexity and redundancy in apoptosis pathways has made identification of downstream effectors of the JNK pathway far more challenging. In such a situation, identifying the key initiator kinase/s that activate/s beta cell apoptosis would provide clear and attractive targets for therapeutic intervention. We have recently found that cytokines upregulate the expression mixed lineage kinases (MLKs) in pancreatic beta cells. The specific aims to be addressed in this grant include 1) Demonstration of a causal role for MLKs in induction of beta cell apoptosis using animal models of type 1 and type 2 diabetes. 2) Examine downstream molecular mechanisms by which mixed lineage kinases regulate beta cell death. [unreadable] 3) Examination of post-translational mechanisms that regulate the activation of MLKs in the pancreatic beta cell. [unreadable] [unreadable] [unreadable]